RNA-binding as a new paradigm for androgen receptor-mediated prostate cancer therapeutic resistance

Project Summary
Given that prostate cancer is primarily driven by androgen receptor (AR) signaling, AR-targeting therapies
have been the mainstay treatment for advanced prostate cancer. However, despite the advent of second-
generation potent AR-pathway inhibitors such as enzalutamide, apalutamide, and abiraterone, disease
progression after AR-targeting therapies remains a major challenge. AR reactivation drives disease
progression in at least 70% of cases. AR can be reactivated through multiple mechanisms, with AR gene
amplification and/or overexpression being particularly common. Understanding how AR resists these therapies
is crucial for devising strategies to delay or prevent progression to incurable stages.
The proposed study addresses this urgent need. Our preliminary studies have uncovered a novel role for AR in
enhancing splicing fidelity, extending beyond its classical transcriptional activity. We also discovered that AR
possesses potent RNA-binding activity, which is not impacted by current AR-targeting therapies, including
enzalutamide. The overlap between AR’s RNA and DNA targets is limited. Instead, AR binds to the transcripts
of over 130 splicing factors and positively regulates the expression of many of these post-transcriptionally. This
regulation is consistent with the elevated levels of these splicing factors during disease progression.
We hypothesize that AR binds splicing factor (and other) pre-mRNAs to promote the expression of key splicing
factors, leading to efficient splicing and expression of genes critical for prostate cancer progression and
resistance to AR-targeting therapies. This hypothesis will be tested through two specific aims utilizing clinically
relevant model systems and clinical datasets. Aim 1 will elucidate the impact of AR-RNA interactions in
prostate cancer progression and resistance to AR-targeting therapies. Aim 2 will determine the mechanisms by
which AR regulates pre-mRNA splicing.
Decades of research on AR have predominantly focused on its DNA-binding activity. The outcome from this
study could transform our understanding of AR’s functions and its molecular contributions to prostate cancer
progression and therapeutic resistance. It could also radically change the way we think about targeting AR for
effective management of prostate cancer.

Public health relevance
Project Narrative Despite the introduction of new hormone therapies for metastatic prostate cancer like enzalutamide, apalutamide, and abiraterone, disease progression following these treatments remains a major challenge in clinical management. The proposed research is relevant to public health because it addresses a new and important mechanism of resistance to current hormone therapies. The findings from this study are anticipated to have a significant impact on developing rational strategies to more effectively treat prostate cancer.